Desensitization of beta1 adrenergic receptor-nitric oxide signaling in cardiac diseases

Emerging evidence indicates that nitric oxide (NO) is involved in cardiac β1 adrenergic receptor
(β1AR) stimulation of cardiac function. We propose that scaffold protein SAP97 plays a critical
role in regulation of cardiac β1AR-induced NOS1-NO signaling cascade via organizing a β1AR-
NOS1 signalosome. This pathway is necessary for regulation of cardiac contractile function. We
also hypothesize that G-protein kinase 5 (GRK5) promotes phosphorylation of cardiac β1AR
PDZ motif and dissociation of the receptor from the SAP97-organized signalosome for activation
of NOS1-NO signaling and promotes desensitization of receptor signaling in cardiac diseases.
We will test the hypotheses with the following aims. Aim 1. SAP97 regulates β1AR-induced NO
signaling in heart. Aim 2. SAP97 maintains the integrity of β1AR-SAP97-NOS1 signalosome to
preserve cardiac function. Aim 3. GRK5 promotes desensitization of β1AR-NO signaling via
disruption of the receptor-SAP97 signalosome in heart failure.

Public health relevance
We aim to characterize the essential roles of two proteins GRK5 and SAP97 in reduction (desensitization) of adrenaline stimulation of a signaling molecule nitric oxide to enhance cardiac output. We will find how this regulation goes wrong in heart diseases and thus offers novel strategies to treat heart diseases.